Neural processing of communication sounds: acoustic features and semantic content

Acoustic communication is crucial for social interactions in many species, including humans.
Understanding the neural underpinnings that govern the production and processing of communication sounds is
paramount to advance the fields of auditory neuroscience and social behavior. Studies investigating speech and
sound processing in humans have mostly implemented non-invasive methods, leaving a gap in knowledge about
underlying neural mechanisms. My project bridges this gap by exploiting scientific advantages of echolocating
bats, mammals that produce and process a rich repertoire of acoustic signals, to investigate the circuits that
contribute to the discrimination of complex sounds that carry different meanings. Bats are social mammals with
well-developed audio-vocal systems and produce ultrasonic vocalizations for navigation and social
communication, providing a distinct opportunity to study the pathways, molecules and brain regions, which
enable complex sound processing. Aim 1 combines behavior and neurophysiology to investigate the specific
acoustic features of communication calls that are key to evoke behavioral responses and the neural systems
involved in sound discrimination. Aim 2 combines psychophysical, neurophysiological, and pharmacological
inactivation methods to study the midbrain-amygdala circuit’s role in mediating discrimination of sounds that
show overlap in spectro-temporal features but carry different semantic content. Aim 3 investigates circuit
phenomena in a social context by combining neurophysiological recordings and targeted pharmacological
inactivation in freely interacting bats. The overarching hypothesis of this research program is that social-
emotional processing of auditory stimuli through a midbrain-amygdala circuit mediates the discrimination of
sounds that carry different meaning. The significance of this project resides in the extraordinary scientific
opportunities to bridge studies of auditory behaviors, single neuron recordings, circuit dissection and
computational modeling in a mammalian model. This work will contribute key new knowledge of natural sound
processing mechanisms in mammals that could inform a deeper understanding of human auditory
communication disorders. This supplement will enable the training of Zaria George to carry out Aim 3 of the
project. The University of Illinois at Chicago offers an outstanding environment to conduct the independent
portion of this project, as it provides access to world class research facilities, seminars and workshops offered
by the Laboratory of Integrative Neuroscience; along with an extraordinary network of colleagues and
collaborators.

Public health relevance
Project Narrative Acoustic communication is at the center of our everyday lives and impedances on it directly affect our well- being. The results of my proposed research will bridge a critical gap in our understanding of the neural mechanisms mediating the auditory processing of social sounds in mammals and will pave the way to new predictions and hypotheses on speech and natural sound processing mechanisms in humans. By leveraging bats as auditory specialist animal models, the project will yield new discoveries on sound processing, which is a necessary first step towards therapeutic interventions for individuals for whom auditory processing may be challenging.